SESAME: Sun Exposure and Activities after Skin CAncer: Optimization of Mhealth IntErventions

ABSTRACT
There are currently 1.36 million melanoma survivors in the US, and this number is expected to increase to 1.92
million by 2030. Most melanoma patients (92%) survive 5 or more years but face an increased risk of new
primary melanoma. Although survivors are recommended to practice sun protection, sunburns remain common
among this population. The few sun protection interventions that target at-risk adults have had weak or mixed
effects on sun protection, despite often comprising multiple components. Mobile health (mHealth) approaches
to reducing unprotected sun exposure, which are highly acceptable among melanoma survivors, hold potential
for delivering actionable real-time information on sun protection and exposure but have not been designed to
account for sun protection in real time, and little is known about which mHealth components optimize effects on
unprotected sun exposure. Further, there is growing evidence to suggest moderate-to-vigorous physical
activity (MVPA) decreases after melanoma diagnosis, potentially due to heightened concerns about spending
time outdoors (thus, decreasing opportunities for outdoor MVPA). Therefore, it is essential that sun protective
interventions do not unintentionally reduce MVPA, a health-enhancing behavior. However, few studies have
explored these relationships. Guided by the Multiphase Optimization Strategy (MOST) framework, the purpose
of this study is to refine and enhance our existing intervention tools in preparation for a fully-powered factorial
experiment to determine what intervention components optimally reduce unprotected sun exposure, and
determine their effects on MVPA. We build on technological and methodological foundations of our prior work,
including an alignment algorithm that combines information from an ultraviolet radiation (UVR) sensor,
actigraphy, and our validated end-of-day Minutes of Unprotected Sun Exposure (MUSE) self-report survey to
determine time spent outdoors, MVPA, and protection-adjusted UVR dose. In Aim 1, through user-centered
design, we will refine intervention tools, including a SESAME app that integrates a UVR sensor and simplified
MUSE survey to quickly assess real-time sun protection. In Aim 2, we will test the feasibility and acceptability
of promising intervention components and research trial procedures in preparation for a future clinical trial that
uses a highly efficient experimental strategy powered to detect effects of individual components on unprotected
sun exposure and accelerometer-measured MVPA. Components include: in-the-moment UVR alerts and UVR
feedback, sun protection monitoring and feedback, UVR weather reports, e-coaching, and action planning.
Findings will inform a fully-powered MOST factorial experiment with components that are effective and
acceptable by melanoma survivors. As an exploratory aim, we will evaluate the effects of each intervention
component on MVPA. Knowledge gained from this study will inform development of more effective,
implementable, and scalable interventions to reduce disease burden in this population.

Public health relevance
PROJECT NARRATIVE Despite having an increased risk of developing new melanomas, melanoma survivors often do not engage in adequate sun protection, and the best set of interventions to help improve sun protection is not yet known. Given the promise of technology, in this project, we refine and test a mobile health intervention system that captures real-time sun exposure adjusted for self- reported sun protection use during outdoor activities and delivers up to 5 additional intervention components. This study will determine which intervention components are feasible, acceptable, and demonstrate preliminary efficacy in decreasing unprotected sun exposure..